RENAL INPUT TO SPINORETICULAR AND SPINOTHALAMIC NEURONS

Renal afferent fibers relay information from renal mechanoreceptors and chemoreceptors to the central nervous system. This information is responsible for activating renorenal reflexes, initiating renal pain, and contributing to regulation of blood pressure. The mechanisms by which renal afferent information alters activity in the central nervous systems are unknown. This research will test the following hypotheses: 1) electrical stimulation of renal afferent fibers alters activity of spinoreticular and spinothalamic neurons in the lower thoracic and upper lumbar spinal cord; 2) spinoreticular neurons are responsive to renal stimuli which elicit cardiovascular and renorenal reflexes; 3) noxious renal stimuli activate spinothalamic neurons. These hypotheses will be tested in experiments on alphachloralose anesthetized cats. Extracellular potentials will be recorded from cells in the spinal cord which project either to the medial reticular formation or the contralaternal thalamus. After locating a cell, its responsiveness to electrical stimulation of the renal nerves will be examined and the type of fiber input responsible for the responses determined. Each cell will also be tested for responsiveness to somatic stimuli. More natural stimuli will be used to excite renal receptors, including increases in renal venous pressure, renal arterial pressure, and ureteral pressure to activate renal mechanoreceptors. Renal chemoreceptors will be activated by prolonged renal artery occlusion and by back perfusion of various solutions into the renal pelvis. Noxious stimuli will include injections of algesic chemicals into the renal circulation and severe distention of the renal pelvis. The responses of spinoreticular and spinothalamic neurons to these maneuvers will be determined as well as the stimulus intensity - cell response relationship. The information gained from these experiments will provide a basis for understanding renal pain, renorenal reflexes, and the possible participation of renal receptors in hypertension.